Uncovering physiological and genomic mechanisms that enable dehydration tolerance in rodents

Humans are exquisitely sensitive to dehydration, and thousands of people die every year as a direct result of dehydration. Countless others suffer physiological and cognitive impairment. This research proposal aims to uncover the physiological and genomic mechanisms that enable dehydration tolerance in rodents, with the goal of developing strategies that can improve human health and wellbeing by enhancing our own tolerance. Dehydration, a condition that arises when fluid loss exceeds fluid intake, often leads to electrolyte imbalances, cognitive impairment, organ failure, and death if untreated. It poses significant health risks to vulnerable populations like the elderly, children, and individuals with chronic illnesses, and others that do not have sufficient access to potable water. As access to clean water intensifies the prevalence of dehydration-related illnesses and deaths may increase. By studying how rodents successfully mitigate water loss through adaptive strategies like reduced metabolism, activity, and body temperature, this research aims to identify some general strategies that are beneficial. Further, the research seeks to identify key molecular pathways that could be harnessed to treat and prevent dehydration in humans. Investigating the activation of biochemical pathways, such as the RAAS system and the vasoactive molecule 20-HETE to preserve organ function in these resilient animals could provide innovative treatment strategies for minimizing dehydration-related health risks in humans. Understanding these mechanisms is crucial as we experience greater challenges with our global health infrastructure, especially in regions with limited access to clean water.

Public health relevance
The proposed work investigates the physiological and genomic mechanisms of dehydration tolerance in rodents. By examining how these rodents reduce their metabolism and activity, conserve water, and activate key biochemical pathways like the RAAS system and 20-HETE expression, the research aims to uncover strategies to protect organ function. The insights gained could inform new treatments for dehydration-related health issues in humans.